CONTINUOUS INSULIN INFUSION IN DEPENDENT DIABETES MELLITUS

Diabetic subjects with various degrees of control based on their plasma glucose an HbA1c are studied before insulin pump treatment is instituted. We determined triglycerides in plasma and 3 chylomicron VLDL subfractions isolated by density gradient ultracentrifugation before and following fat ingestion. The lipid and apoprotein composition of the post-prandial particles is also determined overtime.